Circular RNAs in Cholestatic Liver Diseases

Primary sclerosing cholangitis (PSC) is a major cholestatic liver disease with high morbidity and mortality.
Inflammation and fibrotic injury of the bile ducts due to impairment of bile formation or flow represent the major
characteristics of PSC. A large fraction ( about 98%) of the transcribed mammalian genome is noncoding RNAs
(ncRNAs), including long noncoding RNAs (lncRNAs), circular RNA (circRNAs), and microRNA (miRNAs).
However, the biological functions of ncRNAs remain largely unknown. As the first identified and well-
characterized lncRNA, aberrant expression of lncRNA H19 has been associated with numerous human diseases,
including liver diseases. CircRNAs are a large emerging class of ncRNAs that are important regulators of various
physiological and pathological processes. Recent advances in high-throughput RNA sequencing and circRNA-
specific bioinformatics algorithms have identified thousands of circRNAs with tissue-specific expression patterns.
However, the relevance and function of circRNAs in disease, especially in liver diseases, remain to be
determined and is the focus of this new application. We reported that aberrant expression of H19 is associated
with the severity of cholestatic liver injury in Mdr2-/- mice. Our new preliminary data showed that 1) Key genes
involved in inflammation, fibrosis, and senescence, as well as sphingolipid metabolism, were upregulated in both
bile duct ligation (BDL)-mice and Mdr2-/- mice; 2) The number of cholangiocytes, pro-inflammatory macrophages
and activated stellate cells were significantly increased, while the number of Kupffer cells (KCs) was significantly
reduced in Mdr2-/- mice; 3) Deletion of H19 reduced cholestatic liver injury in both BDL and Mdr2-/- mice; 4) The
deletion of RNA binding protein HuR (human antigen R) upregulated H1926. 5) Arraystar circRNAseq identified
33 overlapping circRNAs, which were significantly upregulated in Mdr2-/- mice and downregulated in Mdr2-/-/H19-
/- mice. Among them, mmu_circRNA_26644 (circRNA-Edil3) and mmu_circRNA_19966 (circAff3) are among
the most significantly regulated circRNAs by H19; 7) Sequence analysis suggested that circRNA-Edil3 and
circAff3 may serve as a "sponge" for miRNA-215-3p, miRNA-129-5p, miRNA-212-5p, and miRNA-185-3p; 5)
Previous studies have shown that these miRNAs inhibit HSC activation and suppress fibrogenic signaling
pathways by targeting high mobility group box protein 1 (HMGB1), Edil3 and Aff3. Based on our published results
and a large amount of exciting new preliminary data, we HYPOTHESIZE that H19-induced upregulation of
circRNAs plays a critical role in cholestatic liver fibrosis by sequestering miRNAs and HuR. Two specific
aims are proposed to test our hypothesis. Aim 1 is to examine the role of H19-induced upregulation of
circRNAs (circEdil3 & circAff3) in regulating cholangiocyte proliferation, senescence and hepatic
inflammation. Aim 2 is to identify the mechanisms by which H19-induced circRNAs promote cholestatic
liver injury. Completion of our proposed studies will elucidate the potential cellular/molecular mechanisms
involved in the progression of cholestatic liver diseases and identify novel diagnostic and therapeutic targets.

Public health relevance
Cholestatic liver disease, such as primary sclerosing cholangitis (PSC), is a critical clinical problem associated with high morbidity and mortality but no available FDA-approved treatment due to the limited understanding of the pathogenic mechanisms. Noncoding RNAs, such as long noncoding RNAs (lncRNAs), circular RNA (circRNAs), and microRNA (miRNAs), are important regulators of various physiological and pathological processes. The focus of this application is to examine the role of lncRNAh19-mediated dysregulation of circRNAs (CircEdil3 &CircAff3) in cholestatic liver injury and further identify the underlying cellular/molecular mechanisms for developing potential diagnostic and therapeutic strategies for PSC.